Investigating the mechanobiology of multicellular morphogenesis

Project Summary
The morphogenesis of multicellular systems has important implications in both development and diseases.
Growing evidence suggests that mechanical signals present in the cellular microenvironment as well as the
mechanical state of the cells play critical roles in morphogenetic processes, such as the branching dynamics in
organ and gland development and invasive diseases like cancer, and the spatial organization and patterning of
cells during these processes. Hence, understanding the mechanobiology of multicellular morphogenesis is of
critical importance in both the fundamental biology of development and the treatment of human diseases via
mechanomedicine or mechanical-based therapies. However, the complexity of the multicellular systems,
especially in a three-dimensional physiologically relevant microenvironment, remains one of the biggest
challenges in the field, largely due to a lack of appropriate quantitative tools. My laboratory has been building
skills and developing new technologies to overcome this obstacle, including the engineering of in vitro and ex
vivo multicellular cluster models and extracellular matrices with controlled physical properties, the development
of computational mechanics approaches to quantify forces during branching morphogenesis, and the
development of cell sorting platforms to characterize cellular mechanical phenotypes. In this MIRA application,
we plan to apply and optimize these technologies to address some longstanding questions in the
mechanobiology of morphogenesis. The goals for the next five years will be, first, to measure the distribution of
intercellular mechanical forces during morphogenetic processes, including branch elongation/retraction,
bifurcation/budding, and buckling, and connect these dynamic processes to mechanotransduction signaling and
active cellular force generation. Second, we will engineer cell clusters of different sizes and shapes, and culture
them in different extracellular environments. We will measure and model cellular bioenergetics to understand
energy-driven morphogenesis. Third, we will sort cells based on their ability to generate contractile forces and
use the sorted cell subpopulations to track and test if cells all actively adapt their mechanical phenotypes to a
new environment or if only a subpopulation with a certain phenotype is selected by the new environment during
development and disease progression. We will further screen and sequence the subpopulations to understand
the genetic basis of the phenotypic difference in contractility. Together, this work will leverage the innovative
tools we have been developing to address mechanobiology questions that were not possible previously,
including how mechanical forces direct different branching dynamics, how cellular energy drives morphogenesis
and cell patterning, and how heterogeneous mechanical phenotypes contribute to development and disease
progression. The overall vision for this research program is for these new tools and new knowledge to help
uncover novel therapeutic targets and lay the foundation for the future development of mechanomedicines.

Public health relevance
Project Narrative The morphogenesis of multicellular systems is important for organ development, tissue regeneration, and for understanding pathological processes like cancer invasion. While it is known that mechanical forces play a critical role in morphogenesis, a complete understanding of the mechanical regulation of morphogenesis is not available, especially in three-dimensional systems, largely due to a lack of appropriate tools. This proposal will address this problem by applying and developing novel engineering tools to calculate the distribution of mechanical forces and energetics in the multicellular systems, and to isolate cell subgroups that have different abilities to generate mechanical forces.